Applications of the long-term culture human primordial germ cell-like cells to toxicological assessments and mechanistic studies on chemically caused heritable human health threats

Because germ cells are exclusively capable of passing the genetic materials to the progeny, damages to their
genome – either involving DNA mutations or only affecting epigenetic machineries – impose a unique risk of
initiating heritable disorders. Whereas toxicants that reduce viability of germ cells may diminish fertility, lesions
in the genome of survived germ cells may be persistent beyond generations to harm health of the offspring.
Because the risk of creating hereditary diseases would increase when the genome of embryonic precursors of
germ cells is impaired, and because sensitivities and genotoxic mechanisms of a toxic substance may vary
among different cell types, assessments of such a risk would be best performed using human germline
precursor cells. However, the lack of cell culture models of human germ cell precursors suitable for in vitro
assessments has been a significant obstacle to understanding the realistic risk that chemical exposure initiates
heritable diseases as well as to develop strategies for protecting the genome of human germ cells. The large
and ever-increasing number of synthetic compounds further raises the hurdle of comprehensive understanding
of such exposure-initiated heritable health threats. The Primordial germ cells (PGC) is the most upstream
precursor of all germ cells. The human PGC-like cell (hPGCLC) is a pluripotent stem cell-derived cell culture
model of human PGCs, but technical difficulties with its in vitro expansion has been preventing its practical use
for toxicological assessments. Our laboratory has recently overcome this hurdle by successfully establishing
the Long-Term Culture hPGCLC (LTC-hPGCLC), which perpetually expands in a serum/feeder layer-free cell
culture condition as a highly homogeneous, senescence-free cell population without losing their PGC-like
characteristics. Taking advantage of LTC-hPGCLCs, this project will obtain critical mechanistic insights into
how environmental chemicals affect genetic and epigenetic integrity of human PGCs through creating novel
nucleotide base mutations (Aim 1) or disrupting the epigenetic integrity (Aim 2). A genetically engineered
variant of LTC-hPGCLCs that are resistant to stress-induced cell death will be exposed to toxicants directly or
in the context of organ cultures mimicking the micro-environment of human embryonic testis. Aim 1 will
examine DNA damaging effects of cigarette smoke mutagens, drugs commonly used for cancer
chemotherapy, and nanoparticles whereas Aim 2 will examine epigenetic effects of endocrine disrupting
chemicals and the PFAS chemicals, which are used as stain repellants, polishers, paints, and coatings.
Attempts will also be made to develop high-throughput compatible assays for evaluation of these genotoxic
actions of chemicals in LTC-hPGCLCs. Outcomes of our research will directly inform not only the scientific
research community but also the industry and the governmental programs regulating chemical safety about the
risk of creating familial diseases via exposure to toxic substances. Our study will also inform the translational
toxicology approaches to develop clinical interventions for protection of human germ cell genome.

Public health relevance
Whereas evidence is accumulating that exposure of pregnant women to toxic substances may initiate hereditary diseases that run in the family with or without involving DNA mutations, our knowledge about how various types of toxicants can introduce persistent damages into the genetic materials of human germ cell precursors responsible for production of sperm or eggs has been limited due to the lack of convenient experimental model of such precursor cells. Taking advantage of our recent accomplishment that enables perpetual expansion of human germ cell precursors in the laboratory as cell culture, we propose a research project aiming at examining persistent damages in the genetic materials of germ cell precursors caused by exposures to toxic chemicals. Outcomes of our research will immediately teach not only academic research laboratories but also the hospital clinicians, the industry, or the governmental agencies regulating chemical safety about the risk and mechanisms of heritable damages caused by exposure to environmental chemicals or therapeutic drugs, including chemotherapy agents.